MECHANISMS OF CYTOCHROME P-450 ENZYMES

Cytochrome P-450 comprises of a large super family of hemoproteins that collectively catalyze the metabolism of literally thousands of different compounds, including steroids, fatty acids, drugs and carcinogens. Although the general sequences of events that occur during the action of these enzymes are understood, and are common to all members of the family, the mechanism by which a substrate is converted to several metabolites is frequently obscure. Several mechanisms may be envisioned. In each of the mechanisms, the substrate combines with the enzyme in different orientations to form complexes that then are activated to a set of (EOS) complexes. The fate of these (EOS) complexes determine the mechanisms. In the parallel pathway mechanism, the (EOS) complexes are so stable and rigid they cannot be converted either directly or indirectly to complexes with different orientations; the orientation of the (ES) complex thus determines which metabolite will be formed. In the nondissociative mechanisms, the complexes are not rigid; instead they undergo interconversion while the substrate remains in the active site of the enzyme. In the dissociative mechanisms, the (EOS) complexes dissociate to (EO) and (S) but recombine to form (EOS) complexes with either the same or different orientations. We have derived steady-state rate equations for each of them and used them to elucidate the mechanism by which P-450 2C11 converts dO-testosterone and d5-testosterone to 2a- hydroxytestosterone on the one hand and 16a-hydroxytestosterone and androstenedione on the other. The results reveal that the metabolites are not formed by the nondissociative mechanisms. Some of the results indicate that the metabolites are formed by the general dissociative mechanism, but other results indicate that the parallel pathway mechanism may be invoked under certain conditions.